TRIAL OF EFV/NFV IN COMBO WITH ZDV/3TC/IDV IN AIDS

ACTG 388 is designed to determine the virologic benefits and safety of either NFV or EFV in combination with combivir and indinavir in the treatment of subjects with advanced disease and antiretroviral naive.